Investigator Development Core

Modified Project Summary/Abstract Section

Preparing researchers to gain skills and health disparities (HD) expertise is vital to addressing health research. Thus, investigator development remains an essential component of capacity building for HD research. Multiple departments across NCCU offer a pool of faculty and scientists who will be targeted and supported for career advancement in these areas.

Public health relevance
Modified Public Health Relevance Section Persistent gaps in access to quality care among U.S. communities contribute to worsening health outcomes and remain a critical public health challenge. The role of HBCUs in addressing and being represented in the community has proven to be essential to address health challenges through research and community engagement. Through this competitive renewal, NCCU's RCMI Center for Health Disparities Research (RCHDR) will continue enhancing NCCU's research ecosystem to develop successful scientists conducting impactful and cutting-edge research that aim to improve health outcomes for all populations.